Elucidating the RNA-mediated mechanisms governing H3K9me3 deposition in fragile X syndrome

Project Summary
Fragile X Syndrome (FXS) and Fragile X-associated/Tremor Ataxia Syndrome (FXTAS) are two FRAXopathies
which are characterized by the unstable expansion of a CGG short tandem repeat (STR) located in the 5'
untranslated region of the Fragile X Mental Retardation 1 (FMR1) gene. Expansion of the CGG tract from wild
type length (WT, <55 CGG STR) to premutation (PM, 55-200 CGGs) results in a dramatic increase in FMR1
transcription with no noticeable elevation in levels of the protein it encodes (FMRP). Upon expansion to full
mutation (FM, >200 CGGs), FMR1 is silenced via DNA methylation and, consequently, FMRP also reduces to
baseline levels. Neither the removal of DNA methylation over the promoter and CGG tract nor transgene
rescue cannot fully restore healthy phenotypes suggesting FMR1 and FMRP dysregulation are not the only
disease drivers. The objective of my proposal is to investigate the RNA-mediated mechanisms driving
disease-associated H3K9me3 deposition, trans interactions, and genome-wide STR instability in FXS. My
central hypothesis is that FMR1 or FMR1-AS1 RNAs influence pathological heterochromatin deposition in a
CGG length-dependent manner by toggling between sequestering key chromatin readers, writers, and erasers
in inclusion bodies and forming toxic DNA:RNA structures locally and at distal loci. I have formulated my
hypothesis based on our recent surprising observations that (1) Megabase-scale heterochromatin domains
are acquired on autosomes and the X chromosome and spatially connect in ectopic inter-chromosomal
interactions FM FXS in a manner that is dependent on the length of the CGG STR and (2) cut-back of the FM
CGG to PM, or overexpression of PM-length CGG RNA, can reverse pathologic H3K9me3 deposition in FXS.
Moreover, in established literature, PM-length CGG RNA forms nuclear inclusion bodies, whereas FM-length
CGG can form toxic DNA-RNA R loops, but their interplay during FXS onset and progression and mechanistic
connection to heterochromatin is unknown. I will test my hypothesis by employing state-of-the-art techniques
like CUT&RUN, Hi-C, MapR, RADICL-seq, and ChlRP-MS in induced pluripotent stem cells differentiated to
neural progenitors (iPSC-NPCs) across a range of CGG STR expansions and engineered cut-backs to shorter
tracts. Upon successful completion of my experiments, I will elucidate the protein components of nuclear CGG
RNA inclusion bodies, the location and sequence of RNA:DNA hybrids and R loops, heterochromatin
placement, and genome folding features genome-wide as a function of CGG expansion and contraction. My
work is significant because ii will elucidate the mechanisms by which FXS might progress via RNA-mediated
heterochromatin in subnuclear bodies and established fundamental knowledge about the interplay between
RNA-based inclusion bodies and RNA-DNA hybrids genome-wide in repeat expansion disorders. Our models
of genome-wide heterochromatinization and gene silencing in FXS will also shed light on possible new
mechanisms for H3K9me3 in other human conditions such as cancer, neurodegeneration, and aging.

Public health relevance
Project Narrative Fragile X syndrome is the most common form of heritable intellectual disability and autism spectrum disorder. While this disease has been linked to instability and methylation of a short tandem repeat tract at a single gene, FMR1, we have shown that there are several other locations in the genome that are affected by pathologic Megabase-scale H3K9me3 deposition. Using cutting-edge genomics, mass spectrometry, and computational assays, we will investigate the RNA mechanisms driving heterochromatin-mediated gene silencing via inter-chromosomal interactions in fragile X syndrome.